Non-human primate MHC and KIR Allele Discovery and Typing Technology Development

The program aims to enhance immunological and infectious disease research using nonhuman primate (NHP) models by providing detailed knowledge of NHP Major Histocompatibility Complex (MHC), Killer-cell Immunoglobulin like Receptor (KIR), and Fc Receptor (FcR) genes, loci, and alleles. It also aims to develop genotyping technologies that are freely accessible to the NHP research community and provide all sequences generated to NIAID-designated, publicly available databases. The program also aims to develop and apply whole genome/whole exome sequencing (WGS) to the MHC, KIR, and FcR regions, and generate and make publicly available supplemental information, including primer and probe definitions and familial relationships of animals used in gene discovery and allele frequency studies. This information will support the development and interpretation of transplantation and other studies in the NHP pre-clinical model.